CALIBRATION OF GAS EXCHANGE EQUIPMENT IN THE GCRC EXERCISE LAB

The purpose of this protocol is to conduct "validation" trials gas exchange and exercise equipment located in the GCRC at the Mayo Clinic. This testing equipment is very similar to the systems already in place in the Pulmonary Function Lab and the Cardiovascular Health Clinic at the Mayo Clinic. This technique will be the most convenient way to make sure all three systems operating at the institution output similar and accurate results. As a result of these studies, GCRC investigators now have a wider range of exercise testing methods to choose from.